Driving Biomedical Projects

DRIVING BIOMEDICAL PROJECTS SUMMARY
Development of new technology is driven by the desire to perform experiments for which the tools do not yet
exist. Our driving biomedical projects are selected because they each have biologically significant open
questions that motivate our specific technology development projects. They have unique features that either
facilitate intermediate steps in technology development or make them particularly well-suited to demonstrate
the power and impact of our new technology. They are chosen to represent a broad cross-section of biological
systems, including channels, transporters, signaling proteins, enzymes, protein/nucleic acid complexes, and
intrinsically disordered proteins. Application of our new technology to these projects also has the potential to
impact our understanding of a number of different biomedical conditions and diseases. Together, this set of
DBPs provides an initial test bed for our technology and opportunity to demonstrate the broad scope of
potential applications for our technology.